Targeting GPR84 to Overcome Macrophage Mediated Resistance to Immunotherapy

Project Summary
Immune checkpoint blockade (ICB) has produced extraordinary clinical responses in more than 25 tumor
types. However, only a small number of patients benefit from this therapy owing to the immunosuppressive tu-
mor microenvironment (TME). As one of the major components of the TME, tumor-associated macrophages
(TAMs) usually possess profound inhibitory activity against tumor-killing T cells and facilitate tumor escape
from immunotherapy. Clinical findings have shown that the presence of suppressive pro-tumorigenic TAMs
correlates with reduced survival in bladder cancer patients treated with immunotherapy. Due to the plasticity of
macrophages, excitement has been growing to reshape the pro-tumorigenic TAMs toward the anti-tumorigenic
phenotype to stimulate the immunity against cancer. Emerging evidence reveals that this process of macro-
phage polarization is inextricably affected by metabolites in the TME, such as free fatty acid (FFA). Lack of
data regarding the role of FFA signals in macrophages prevents us from designing an elegant approach to re-
polarizing TAM to foster a better anti-tumor T cell response. We propose to dissect the molecular basis of the
FFA-mediated signal pathway in TAMs differentiation and its role in resistance to PD-1 blockade, which can be
leveraged to restore sensitivity to ICB therapy. Our analysis of published datasets revealed that TAMs from
human bladder tumors uniquely express elevated levels of a fatty acid receptor, G Protein-Coupled Receptor
84 (GPR84). These GPR84 expressing cells exhibited enriched hallmarks of anti-tumorigenic function com-
pared to their counterpart. Further analysis reveals that expression of GPR84 significantly correlates with
longer survival in bladder cancer patients. Our work shows that genetic ablation of GPR84 leads to enhanced
production of inhibitory molecules including Arginase 1 via activation of CCAAT/enhancer-binding protein beta
(C/EBPβ). By contrast, GPR84 activation by its agonist 6-OAU can reprogram pro-tumorigenic macrophages to
produce anti-tumorigenic signature molecules, such as tumor necrosis factor-α (TNFα). Mechanistically, we
found that GPR84 potentiates the activity of Nuclear factor kappa B (NF-κB) to enhance TNFα production.
Central hypothesis: GPR84 serves as a metabolic signaling checkpoint for determining the function of macro-
phage by restricting the immunosuppressive while promoting the immune-stimulating phenotype. Treatment
with GPR84 agonists significantly retards tumor growth and increases the anti-tumor efficacy of anti-PD-1 mAb
therapy in a MB49 bladder cancer model. Aim 1: Determine whether the lack of GPR84 promotes the polariza-
tion of immunosuppressive TAMs. Aim 2: Dissect the molecular and epigenetic mechanisms by which GPR84
signaling promotes an immune-stimulating phenotype in macrophages. Aim 3: Determine whether targeting
GPR84-mediated macrophage repolarization enhances the anti-tumor efficacy of ICB. Results will inform the
development of promising treatments to reshape immunosuppressive TME through manipulation of metabolic
signaling, and thereby restore responsiveness to PD-1 blockade for bladder cancer patients.

Public health relevance
Project Narrative Immune checkpoint blockade (ICB) produces extraordinary clinical responses in more than 25 types of tumor, but only a small number of patients benefit from this therapy. Our data support a provocative model that G Pro- tein-Coupled Receptor 84 (GPR84) pathway can be pharmacologically activated to shape macrophages to- ward the anti-tumorigenic phenotype to overcome ICB therapy resistance. Results will inform the development of promising treatments to reshape immunosuppressive tumor microenvironment through manipulation of met- abolic signaling, and thereby restore responsiveness to PD-1 blockade for bladder cancer patients.